Core A: Administrative, Career Development and Research Integration Core

ADMINISTRATIVE CORE ABSTRACT
The overarching goal of the Administrative, Career Development and Research Integration Core (Core A) of
the Centers of Biomedical Research Excellence (COBRE), Center for Molecular Epidemiology at Dartmouth is
to promote the development of the Center as an independent, sustainable, and comprehensive resource for
molecular epidemiology in New Hampshire and beyond. The Core is the central organizing entity and a highly
visible feature of the Center. It provides the mentorship structure and intensive career development plans to
strengthen junior investigators' successful attainment of independent NIH funding and continued progress in
their careers. In Phase II, the Core will supply the critical administrative support to strategically recruit new
faculty (e.g., at least two junior and one senior faculty members) and new members (e.g., bench or clinical
scientists) who will foster the goals and thematic areas of the Center. Additional mentoring and training
opportunities will include a regional symposium on emerging topics in molecular epidemiology and specialized
workshops on innovative technologies (i.e., in epigenetics, metabolomics, microbiome, and mediation
analyses). The Core will coordinate the integration of shared research activities between Center members and
utilization of existing resources within other COBREs and centers. It will facilitate resource sharing and
scientific exchange within the Center, the Institutional Development Award (IDeA) program, and the broader
scientific community. Further aspects of the core will include overseeing the Center's interdisciplinary Pilot
Program, communication, administrative, fiscal, reporting and compliance functions. Importantly, it will be
responsible for designing and executing an aggressive evaluation plan for the Center to ensure that key
milestones are met.